Intravital 2-photon microscopy enabling 6D single cell RNA seq in immunocompetent glioblastoma xenografts

Intravital 2-photon microscopy enabling 6D single cell RNA seq in immunocompetent glioblastoma
xenografts
A variety of in vitro and ex vivo methods have been used to study mammalian cells deciphering signaling
pathways and validating new drug targets. However, properties of cell isolated from native environment are
unavoidably altered. Histology provides only static information on molecular and cellular processes. Medical
imaging paradigms such as CT, PET and MRI do not allow dynamic visualization of cells at microscopic
resolution in living animals. Recent progress in two-photon (2p) imaging and labeling tools has ushered in a
new era of intravital imaging, which not only enables the longitudinal visualization of cells at high spatial and
temporal resolution, but also sheds light on the function of cells through a variety of indicators. Glioblastoma
(GBM) is the most aggressive and lethal primary brain tumor in adults. There is a pressing need of high
resolution intravital functional imaging tools to interrogate GBM tumor heterogeneity, which is the key
determinant of GBM recurrence and resistance to therapy. This proposal aims to address this pressing need
by establishing an in vivo functional single cell tracking platform with the capacity of molecular profiling. With
extensive research experience in 2p imaging and labeling tools, the PI has developed a cell positioning
system (CPS) for precise, longitudinal functional single cell tracking in live animals. In this proposal, we
combine long-term functional single cell tracking platform with single cell RNA sequencing (scRNA seq).
Compared with conventional scRNA seq, two more dimensions are added: time (t) and cell function (f),
constituting the 6D scRNA seq (x, y, z, color, t, and f). 6D scRNA seq will be used to delineate the molecular
features of GSCs whose cellular behaviors have been collected during 2p imaging. If successful, this 6D seq
platform will significantly advance the field of single-cell sequencing and provide an enabling technology that
promises a more in-depth understanding of the pathogenesis and therapy of brain cancers or other diseases.
Our platform also allows comprehensive in vivo evaluation of tumor responses to chemotherapy as a drug in
vivo screening platform toward establishing individualized targeted therapy for GBM and beyond.

Public health relevance
Observing cells deep within the tissues of a living mouse over time at microscopic resolution is a much-coveted dream that comes true by the recent progress in developing intravital two-photon (2p) imaging and labeling tools. In the fight against glioblastoma (GBM), which is a devastating disease with a very low survival rate, we will borrow these tools from the field of neuroscience to reveal novel insights on pathogenesis and treatment of this disease. In this proposal, we aim to establish the 6-dimmensional single cell RNA seq by incorporating intravital functional single cell tracking to conventional single cell RNA seq for in vivo interrogation of cellular and molecular heterogeneity of GBM. .